Insights from Mural Cells for Precision Medicine in Brain Arteriovenous Malformations

PROJECT SUMMARY
Brain arteriovenous malformations (bAVMs) are dysplastic vascular tangles that pose a significant risk for
intracerebral hemorrhage (ICH). Current clinical and genetic prognostic factors remain imprecise in assessing
hemorrhagic risk, underscoring the need for molecular classification. While bAVMs originate in endothelial cells,
increasing evidence suggests that vascular stabilizing mural cells, such as smooth muscle cells and pericytes,
are critical to bAVM stability and serve as cellular predictors of hemorrhage risk. Preliminary bulk RNA-
sequencing findings from my laboratory show that mural cell depletion in adult bAVMs is associated with an
aberrant immune response, whereas pediatric bAVMs exhibit unique angiogenic-like features, including Notch
activation and TGFβ downregulation, suggesting an alternative mechanism of mural cell loss.
This project aims to develop a multi-modal atlas of the normal and bAVM vasculature to identify non-immune,
angiogenesis-centered disease mechanisms that contribute to mural cell depletion and ICH risk, providing a
foundation for precision medicine strategies. The proposed research consists of two specific aims. First, an
integrated cell and spatial transcriptomic atlas of the non-malformed human cortical vasculature will be created
by harmonizing existing single-cell datasets and performing spatial transcriptomics on surgically resected tissues.
This will provide a comprehensive reference for cerebrovascular studies and enable the identification of spatially
distinct mural cell subtypes along the arteriovenous axis.
Second, a multi-modal study of bAVMs across the lifespan will be conducted to elucidate age-related differences
in disease mechanisms. Single-nuclei RNA/ATAC sequencing will be performed on a large cohort of pediatric
and adult bAVMs to characterize gene regulatory networks (GRNs) associated with ICH risk. Additionally, an in
vitro bAVM organoid model will be developed using induced pluripotent stem cells (iPSCs) carrying KRAS
mutations to functionally validate the roles of Notch, TGFβ, and other identified GRNs in mural cell depletion.
Targeted perturbation experiments using CRISPR activation/interference will assess the effects of these
pathways on endothelial proliferation, mural cell recruitment, and vessel stability.
The anticipated outcomes include a refined molecular classification of bAVMs, identification of novel biomarkers
for hemorrhage risk stratification, and mechanistic insights into mural cell depletion that inform future therapeutic
interventions. By leveraging integrative genomics and advanced organoid modeling, this research has the
potential to transform the clinical management of bAVMs, advancing precision medicine approaches for
cerebrovascular diseases. This work aligns with the broader goal of improving cerebrovascular health and
reducing the global burden of stroke and ICH-related morbidity and mortality and informs precision medicine
approaches to mitigate the risks of bAVM-associated hemorrhage.

Public health relevance
PROJECT NARRATIVE Brain arteriovenous malformations (bAVMs) are a leading cause of intracerebral hemorrhage, yet current prognostic tools remain imprecise for incidentally discovered bAVMs, limiting effective treatment strategies. This research will generate a multi-modal molecular atlas of the normal vasculature and bAVMs across age groups, identifying novel mechanisms of vascular instability and hemorrhage risk while providing a valued reference atlas for the broader blood-brain barrier field. By advancing precision medicine approaches for bAVMs, this work has the potential to improve patient stratification and develop targeted therapies, ultimately reducing the morbidity and mortality associated with these cerebrovascular malformations.